A learning health system approach to using Artificial Intelligence Enabled Decision Support (AEDS) for medication optimization in Veteran Care: An Immunosuppressants use case

Background: In the modern era of drug development, drug manufacturers are regularly introducing novel
medications that require a wide range of resources that may increase the burden for Veterans seeking care.
The VHA must consider how to provide high-quality care in the context of competing resources, the
incremental benefit of novel medications over established treatments, and the needs of Veterans. There is a
critical need and opportunity to optimize treatment with established medications to maximize their benefit and
provide high-quality care considering competing VHA resources and Veterans’ needs. Significance: This
challenge is exemplified in the treatment of inflammatory bowel disease (IBD), a costly and debilitating lifelong
disease with rising resource needs. IBD represents an ideal proof-of-concept and real-world example on which
to conduct research to address: 1. Patient-centered treatment optimization by putting VA Data to Work for
Veterans using novel AI/ML methods, 2. Pre-implementation strategies for adoption, and 3. Optimal
approaches to healthcare utilization (e.g., access to care) using the VA as a Learning Healthcare System–All
of which are VA HSR&D Priorities, updated 3/2023. Innovation & Impact: IBD consists of Crohn’s disease
and ulcerative colitis (UC) and affects nearly 3 million Americans and ~80,000 Veterans. This study addresses
several key gaps in the care of Veterans with IBD by: Adapting and validating prediction models for optimizing
thiopurines; Assessing the usability, acceptability, and feasibility of an Artificial Intelligence (AI)/Machine
Learning (ML)-enabled decision-support systems (AEDS) for thiopurine optimization in the VHA; and
Evaluating the impact of an AEDS-optimized thiopurine treatment policy on clinical outcomes. Ultimately, an
AEDS for thiopurine optimization in Veterans will provide a pragmatic and objective guide for providers to
choose to continue, stop, or modify the course of an IBD therapy to produce optimal outcomes while
maximizing resources in IBD. Specific Aims: Using learning health system framework, we will: Aim 1: Adapt
and validate AI/ML-based models to predict inadequate immunosuppression in Veterans with IBD using real-
world data from the VHA EHR (Data-to-Knowledge). Aim 2: Assess the usability, acceptability, and feasibility of
AEDS for thiopurine optimization in Veterans with IBD (Knowledge-to-Practice). Aim 3: To evaluate an AEDS-
based treatment policy vs. usual care on clinical outcomes (Practice-to-Data). Methodology: In Aim 1, we will
retrospectively identify all Veterans with a diagnosis of IBD on thiopurines in the last 10 years from the VHA
Corporate Data Warehouse. We will adapt and externally validate our previous model among Veterans with
moderate-severe UC on thiopurine monotherapy and internally validate a new model for Veterans with IBD on
combination therapy (thiopurines + anti-TNF biologics). We will use AI/ML-based techniques to assess the
performance characteristics of these models and leverage statistical techniques to address imprecise
measurements in the outcome. In Aim 2, we will elicit behavioral, technological, and systems facilitators and
barriers to successful implementation of AEDS via semi-structured interviews with stakeholders (e.g.,
Veterans, providers, facility leadership, Community Veterans Engagement Board members) using the Unified
Theory of User Acceptance. Findings will be fed back to key health system stakeholders. In Aim 3, we will use
reinforcement learning in an off-policy evaluation comparing an AEDS-based treatment policy vs. usual care on
risk of non-remission and subsequent clinical outcomes (IBD-related steroid use, hospitalizations, surgeries) in
Veterans. Next Steps/Implementation: This study is necessary to develop appropriate pragmatic trials that
inform IBD treatment guidelines and increase adoption of AEDS-guided thiopurine optimization in the VHA. As
a next step, we will apply for an IIR to deploy a prospective pragmatic trial evaluating the effectiveness of
AEDS-guided medication optimization vs. traditional approaches. Ultimately, this work will serve as a template
for positioning AEDS strategies at the point of care to improve health outcomes and access for Veterans.

Public health relevance
Drug manufacturers regularly introduce novel, resource-intensive treatments. There is a critical need and opportunity to optimize treatment with established medications to maximize their benefit and provide high- quality care considering competing VHA resources and Veterans’ needs. This challenge is exemplified in the treatment of inflammatory bowel disease (IBD), a costly and debilitating lifelong disease with rising resource needs. IBD represents an ideal proof-of-concept and real-world example on which to conduct research to address: 1. Patient-centered treatment optimization by putting VA Data to Work for Veterans, 2. Pre- implementation strategies for adoption, and 3. Optimal approaches to healthcare utilization (e.g., access to care) using the VA as a Learning Healthcare System–all of which are VA HSR&D Priorities, updated 3/2023. This work will serve as a template for positioning Artificial Intelligence (AI)/Machine Learning (ML)-enabled decision support strategies (AEDS) at the point of care to improve health outcomes and access for Veterans.